Uncovering the Mechanisms Driving Seasonal Polio Incidence: A Modeling Approach Towards Endgame Strategies

Abstract Wild poliovirus (WPV), which is known to occur seasonally, is on the path towards eradication but continues to circulate in specific regions of the world. The Oral Polio Vaccine (OPV) can indirectly immunize unvaccinated individuals through the seasonal shedding of the vaccine. The seasonal timing of WPV transmission and OPV shedding occur synchronously. Using historical global datasets of reported WPV cases, and state-of-the-art modeling techniques, this work will examine three open questions regarding polio epidemiology: (I) does spatial variation exist in the seasonal timing of WPV outbreaks?, (II) what mechanism(s) are associated with this seasonality?, and (III) how can we improve the global monitoring of polio and expedite final eradication? I take advantage of a recently digitized, spatially resolved, historical dataset of reported WPV infections spanning the 20th century in the United States to examine these questions. I will also include 20th century WPV case data from various African, South American, Middle Eastern, and European countries once the U.S. models are parameterized. The results of this work will diagnose which environmental, demographic, or social factors are most strongly tied to seasonal WPV outbreaks. Understanding when and where a WPV outbreak is most likely to occur and when OPV shedding is at its maximum will allow immunization campaigns to optimize OPV coverage at the local level, and identify the optimal time of year to increase monitoring efforts for WPV. Following WPV eradication, this work can be used towards timing mop-up immunization campaigns, and assist in the monitoring efforts for vaccine-derived polio (cVDPV) strains.

Public health relevance
Project Narrative I will utilize state-of-the-art modeling approaches with historical Wild Poliovirus (WPV) incidence data to identify the mechanism(s) which are most strongly associated with historical WPV transmission across Africa, Asia, the Middle East, Europe, and the Americas. This work will result in mathematical transmission models that can be used to identify the ideal timing for immunization or mop-up campaigns, to maximize Oral Polio Vaccine coverage via indirect shedding. This work will play a crucial role towards eradication, and will also provide epidemiologists with the knowledge of when to look for the re-emergence of WPV or circulating vaccine derived poliovirus (cVDPV) following WPV elimination.